Administrative Core

ABSTRACT
The purpose of the Administrative Core is to provide the leadership and administrative management for the
proposed Pacific Center for Genome Research (PCGR) aimed at capitalizing on the infrastructure at the
University of Hawaii at Manoa (UHM) and the racial/ethnic diversity of its catchment area to conduct genomic
research addressing the racial/ethnic differences in disease risks and outcomes that exist in Hawai`i and the
Pacific. The Administrative Core will build upon a number of institutional resources, both administrative and
scientific, to foster the implementation and coordination of the research in this U54. This Core will also closely
coordinate the U54 resource-building and career-development activities with those implemented by UHM, so
greater efficiency is achieved at the institutional level. Thus, this Core serves major administrative and integrative
functions for the grant. The U54 will rely on an Internal Advisory Committee (IAC), consisting of key senior
scientists on genome research, to receive input on research opportunities and to facilitate coordination with
potentially synergistic local initiatives. The program will also benefit from the input of a Community Advisory
Board (CAB) composed of community leaders and patient advocates with experience in disease disparities
and/or survivorship, and who will advise on the responsiveness of our activities to community needs and
expectations. Program evaluation will heavily rely on the input of an External Advisory Board (EAB) composed
of outside investigators who are leaders in genome research. Specific Aim 1 will be to organize, integrate, and
provide administrative management of all Projects and Cores. Specific Aim 2 will be to provide project
management oversight to track milestones and timelines of the individual Projects and Cores. Specific Aim 3
will be to facilitate collaborations. The Administrative Core will play an essential role in supporting the research
program proposed in the U54. We believe that the skills and experience of Core Co-Directors and the proven
approaches described in this section will provide both the foundation and the building blocks to achieve our
goals.